Effect of exercise modality during pregnancy on childhood obesity risk

Project Abstract
The in-utero environment, including maternal weight gain and exercise habits, can “program” a child towards
disease or health after birth and into adulthood. The often-intergenerational cycle of obesity begins with a
significant number of women who are overweight or obese (OW/OB) at the time of conception and throughout
pregnancy; these women are more likely to give birth to infants who are macrosomic. By age 5, overweight (OW)
children already have signs of metabolic syndrome and cardiovascular disease risks (e.g. obesity,
hyperlipidemia, hyperglycemia, hyperinsulinemia, and hypertension). While research has demonstrated benefits
of both aerobic and resistance exercise for pregnant women as well as decreased adiposity and improved
motor/heart function in their infants, no studies have been done to determine which exercise modes are most
beneficial for mother and baby when a woman is overweight or obese at the time of conception. For adults in
general, combined aerobic and resistance exercise (AERE) delivers the greatest metabolic improvements (e.g.
increased insulin sensitivity, improved heart function, decreased adiposity). Therefore, the purpose of this study
is to identify which prenatal exercise type(s) will elicit the greatest positive impact on maternal and infant health
while reducing metabolic risk markers in OW/OB pregnant women relative to non-exercising counterparts. Using
a randomized design, 284 pregnant women will undergo an exercise intervention (AE, RE, AERE) from
enrollment (~13-16 weeks gestation) until delivery (~40 weeks gestation). The central hypothesis of this study is
that adding RE improves outcomes; thus, the COMBINATION of aerobic and resistance exercise not only will
improve infant cardiometabolic health outcomes, as compared to AE alone, but will have the best compliance of
all groups. We will test this hypothesis with two specific aims to: (1) Determine the influence of different exercise
modes during OW/OB pregnancy on infant cardiometabolic health and growth trajectories; and (2) Determine
the most effective exercise mode in OW/OB pregnancy on improving maternal cardiometabolic health. Methods
will include measurements such as weight, abdominal circumference, blood pressure, lipids, and other
biomarkers for both mothers and infants. The study will also track maternal and infant cardiometabolic outcomes
through the post-partum period, up to 12 months. This work has the potential to impact clinical practice by
revealing the earliest and most effective intervention to reduce the intergenerational cycle of metabolic
dysfunction, including obesity, in women and children.
.

Public health relevance
Project Narrative Factors like maternal obesity and exercise during pregnancy can impact the health of offspring at birth and later in life; little is known about which types of maternal exercise is most beneficial to mother and child, when attempting to break the intergenerational cycle of obesity and metabolic disorders. This study will assess outcomes, for mothers and infants, of three different types of exercise interventions (aerobic, resistance, and combined), comparing expectant mothers with overweight/obesity to a control group. By taking key measurements throughout pregnancy and up to 12 months after delivery, this study will provide insight into the most beneficial mode of maternal exercise for the target population.